INCREASED CARDIAC OUTPUT ON ANP RESISTANCE IN CARDIAC FAILURE

Increased effective arterial blood volume (EABV) in patients with low-output cardiac failure (CHF): reversal of atrial natriuretic peptide (ANP) resistance and attenuation of the inflammatory response to heart failure.